Developing the Caregiver Report of Early Language Interactions (CRELI)

Project Summary / Abstract
Early caregiver-child language interactions strongly influence child language development and numerous
short- and long-term child outcomes, including increased success in literacy and academic achievement.
Because of the public health significance, substantial research has documented evidence-based approaches
that enhance early language interactions in the home and improve child outcomes, yet measurement of the
home language environment and caregiver-child language interactions lags, particularly with respect to
culturally and linguistically responsive measures. There is a critical need for validated tools that specifically
measure language interaction behaviors across English and Spanish and Hispanic cultures to inform and
evaluate interventions for Spanish-English bilingual children in the United States. Currently, tools for measuring
early language interactions are costly, resource-intensive, and have not undergone significant development
with members of Hispanic cultures, limiting equitable measurement and usability in both research and practice.
Further, these tools are difficult to use when implementing interventions at scale. To solve this problem, our
team developed the Caregiver Report of Early Language Interactions (CRELI), a brief, self-report survey about
primary caregivers’ language interaction behaviors with children ages 0-36 months, which no other
questionnaire uniquely captures. Our team has completed initial measurement development steps (expert
reviews, revisions, and initial piloting in English) in preparation for a systematic, simultaneous development
and validation in English and Spanish. Validation of the CRELI in both languages will provide researchers and
providers with a free, scalable, accessible, and culturally relevant tool to measure and monitor progress of
caregiver language interaction behaviors. The purpose of this measurement development project is to develop
the Spanish CRELI, refine the English CRELI, and validate both versions for use in research and practice
focused on caregivers of children ages 0-36 months. We will do this through the following aims: (1) Develop
the Spanish CRELI and refine the English CRELI through focus groups and cognitive interviews with
caregivers and providers; (2) assess the factor structure and psychometric properties of the English and
Spanish CRELI; and (3) evaluate demographic factors that affect performance on the CRELI. The proposed
research will result in a free, validated, culturally responsive measure to assess English and Spanish language
interaction behaviors in a user-friendly and cost-effective manner. This will be invaluable to researchers and
providers as a measure of intervention effectiveness and as a progress monitoring tool. Ultimately, this tool will
help guide improvements in caregivers’ language interactions in English and Spanish in the United States,
which may lead to short- and long-term improvements in academic, health, and economic outcomes for
children, potentially reducing disparities for those in underserved and diverse families across community
contexts.

Public health relevance
Project Narrative There is a need for a validated, easy-to-use measure of language interaction behaviors between primary caregivers and very young children (i.e., 0-36 months) that is also culturally and linguistically responsive. Adapting and validating the Caregiver Report of Early Language Interactions (CRELI) in Spanish and English through the proposed project activities will result in a strengths-based tool for researchers and providers to both evaluate intervention effectiveness and monitor progress in a user-friendly and cost-effective manner. Ultimately, the information gained from the CRELI will strengthen caregivers’ language interaction behaviors to promote short- and long-term improvements in child academic, health, and economic outcomes.